"Role of the cytotoxin, CptA, from the emerging bacterial pathogen Sneathia vaginalis, in pathogenesis"

PROJECT SUMMARY:
Sneathia vaginalis (Sv) is emerging as a pathogen that is significantly associated with preterm birth and can
cause numerous infections including amnionitis, osteoarthritis, meningitis, bacteremia, and urethritis. Due to its
fastidious nature, it has only recently been recognized as a pathogen through the use of DNA-based methods.
Because it has been under-recognized as a pathogen, the biology and the pathogenesis of S. vaginalis remain
almost entirely uncharacterized. We have identified a hemolytic and cytopathogenic toxin produced by S.
vaginalis that we have named CptA. Antiserum against CptA abrogates traversal of Sv across intact human fetal
membranes suggesting that the toxin plays a role in pathogenesis. This project has three main goals. The first
is to assess the maternal and fetal antibody response to CptA during natural colonization/infection. The second
is to establish the role of CptA in traversal of and damage to fetal membranes by Sv. The third is to determine
whether the association between Sv and preterm birth is causal by developing a mouse model of Sv infection
during pregnancy. pathogenesis Characterization of this novel pore-forming toxin will break ground in our
understanding of this emerging pathogen.

Public health relevance
PROJECT NARRATIVE Sneathia vaginalis is very difficult to culture and detect; however, contemporary culture-independent techniques have recently elucidated it as an invasive pathogen capable of causing amnionitis and sepsis in mothers and neonates and it is strongly associated with preterm birth. Through this project, we will break ground in the study of the pathogenesis of a pore-forming toxin produced by this uncharacterized bacterial species through the measurement of antibodies against the toxin in mothers and neonates, characterization of the role of the toxin in fetal membrane damage, and development of a murine model of uterine invasion during pregnancy. This addresses the NIH Healthy People 2020 Objective “Reduce the Rate of Fetal and Infant Deaths”.